Meta-Analysis of Metabolic Determinants of Exercise Response in Common Funds Data

Abstract
Exercise is associated numerous health benefits, but defining the molecular mediators of these effects remains
an active focus of biomedical research. With the advent of the ‘omics sciences, studies including the ongoing
Molecular Transducers of Physical Activity Consortium (MoTrPAC) and multiple smaller-scale efforts have
sought to map the “complete” molecular response to acute and chronic exercise. Much research is currently
focused on integration of genomics, proteomics and metabolomics data within such studies, but another
important strategy is meta-analysis of distinct data sets to evaluate consistencies and differences in molecular
responses observed between different modes of exercise, sex, age, species, and other factors. Of the exercise-
related meta-studies performed to date, most have focused on the genome and transcriptome whereas few have
included metabolomics data. Reasons for this shortcoming include differences in analytical methods,
inconsistency in compound naming and data reporting, and prevalence of unknown features in untargeted
metabolomics data. Unknown metabolite identification and cross-study integration is challenging and requires
application of computational and experimental strategies in a coordinated manner. Yet, the potential benefits are
substantial – identification of novel metabolites and detection of consistent patterns of response have led to
biological insights relevant to fundamental biology and human health, including exercise.
Using data from NIH Common Fund data archives, we propose to develop a multi-study, multi-organism and
multi-condition database of identified and unknown exercise responsive features of the metabolome. We will
integrate data across studies and, when available, across ‘omes, to prioritize and identify unknowns within this
database. We will achieve these goals by carrying out two specific aims: 1) We will perform a comprehensive
survey and alignment of exercise-related small molecule features in MotrPAC data and from studies in the
Metabolomics Workbench. We will use computational tools we have pioneered for metabolomics data cleaning,
inter-laboratory data alignment, and network- and correlation-based analysis to prioritize unknown features for
follow-up. 2) We will systematically track, annotate and identify high-priority exercise-responsive unknown
features in metabolomics data using software and experimental techniques we and others have devised for
MS/MS data collection to identify and annotate features not tractable by routine library search. Our study
represents a crucial step between the map-building aims of MoTrPAC and detailed mechanistic studies of
specific pathways and that hold potential for human health benefits through targeted interventions. We will share
our database and associated data with the research community through publications and uploads to public data
archives. We anticipate our efforts will contribute to improved understanding of the effects of exercise at the
biochemical pathway level and will offer targets for future studies to help delineate the mechanisms by which
small molecules contribute to its salutary effects on health.

Public health relevance
Project Narrative Physical activity is well-known to have numerous health benefits, but the biochemical mechanisms of these effects remain incompletely understood. Using data from National Institutes of Health Common Fund-supported data archives, we will develop a multi-study database of the response of small biological molecules in the body to physical activity. Our efforts will improve understanding of exercise at the level of biochemical pathways and offer targets for future studies seeking to harness this knowledge to improve human health and treat disease.